Ableism as a Mechanism of Physical and Mental Health Inequities Among Children with Visual Impairment

PROJECT SUMMARY
Ableism as a Mechanism of Physical and Mental Health Inequities Among Children with Visual Impairment
According to the Centers for Disease Control, approximately 3% of American children are blind or visually im-
paired – defined as having difficulty seeing even with correction. In the US, over 500,000 children who are
blind or visually impaired (CBVI) experience substantial functional impairments, activity limitations, and par-
ticipation restrictions, which are often exacerbated for CBVI from other minoritized groups. CBVI report lower
health related quality of life and experience higher rates of chronic health conditions and mental health disor-
ders compared to children with typical vision. Despite the prevalence of childhood blindness being greater than
or equal to other rare, but well-researched, childhood conditions (e.g., childhood leukemia), research is virtu-
ally nonexistent regarding psychosocial factors, such as ableism, that impact the physical and mental health of
CBVI. Ableism harms people with disabilities, including CBVI, by excluding them from full access to and par-
ticipation in cultural, educational, occupational, and recreational opportunities. Thus, there is a critical need to
understand how ableism contributes to health inequities experienced by CBVI. The objective of this research
project is to extend and expand our preliminary findings that highlighted a link between experiences of ableism
and poorer physical and mental health of CBVI by: (1) recruiting a first of its kind, large, diverse sample of
CBVI from across the United States; (2) obtaining detailed measures of distal (interpersonal discrimination,
victimization, rejection) and proximal (intrapersonal, affective, cognitive) ableism from the perspectives of
both caregivers and children; (3) using advanced multivariate analytic techniques to identify the contributions
of ableism – beyond other social determinants of health – to physical and mental health outcomes among
CBVI; and (4) obtaining multi-method, multi-informant assessments of physical and mental health status to
further validate our findings. By elucidating the impact of ableism on health inequities faced by CBVI, the pro-
posed research will foster the development of interventions for caregivers, educators, and healthcare providers
aimed at reducing ableist beliefs and actions and thereby having an important positive impact on health out-
comes for this population. We will achieve the overall objectives of this proposal by assessing 500 CBVI ages 9-
17 and their caregivers from across the United States with respect to both distal and proximal ableism (directed
towards the child) and child physical and mental health status. We will collect data on other potentially rele-
vant covariates including social determinants of health; type, degree, and age of onset of visual impairment;
and presence of other disabilities including hearing impairments, developmental disabilities, and motor disa-
bilities.

Public health relevance
PROJECT NARRATIVE Ableism as a Mechanism of Physical and Mental Health Inequities Among Children with Visual Impairment Children who are blind or visually impaired (CBVI) experience high rates of physical and mental health disor- ders, which may be driven by ableism. Ableism harms people with disabilities, such as CBVI, by excluding them from full participation in society, but the specific impact of ableism on the physical and mental health of CBVI has not been examined. The proposed study seeks to identify the role of ableism in driving physical and mental health inequities within CBVI in order to reveal how ableism “gets under the skin” and results in poor health outcomes for these vulnerable children.